MECHANISMS OF FOOD HYPERSENSITIVITY IN ATOPIC DERMATITIS

Studies of dietary prohylaxis in newborns at high risk for atopic disease, and provocation of skin symptoms and immunologic changes by blinded food challengers strongly suggest a significant pathogenic role for IgE-mediated FH in AD. The purpose of this research is to more precisely define the natural history and immunopathogenic mechanisms of food hypersensitivity (FH) in children with atopic dermatitis (AD).